Defining Mechanisms for Parasite-Driven Effects on Gamma-Herpesvirus Latency

PROJECT SUMMARY
The goal of this grant is to understand how bystander infections with intestinal parasites alter chronic
infection with γ-herpesviruses. This is important because herpesviruses infect virtually all people and
approximately a quarter of the world’s population is simultaneously infected with a parasite. Herpesvirus
infections are chronic, but these viruses do not persistently replicate in a healthy host. Instead, they
establish a quiescent infection, termed latency. We discovered previously that co-infection with an
intestinal helminth parasite after infection with γ-herpesvirus led to increased virus reactivation from
latency. We detailed a mechanism whereby reactivation of the virus depended on sensing host cytokines
produced in response to the parasite. A remaining question is whether the timing of the dual infections is
important. In this grant we propose to address this question by changing the order of virus-parasite co-
infection to determine whether reactivation of the virus is increased by parasite infection when the
parasite infection occurs before the γ-herpesvirus infection. We have data to indicate that prior infection
with an intestinal parasite increases γ-herpesvirus reactivation, but that the mechanism is different than
what we discovered previously when parasite infection occurs after the herpesvirus infection. We find
that parasite infected animals have increased resident peritoneal macrophages. We also find that when
retinoic acid, which is required for maintenance of resident peritoneal macrophages, is depleted in mice,
parasite infection no longer increases virus reactivation. Our hypothesis is that parasite infection, in a
retinoic acid dependent manner, alters the tissue composition of resident macrophages. This promotes
retention of a population of infected macrophages with enhanced γ-herpesvirus reactivation. In this
proposal, we aim to examine the role of resident macrophages and retinoic acid in parasite-induced
herpesvirus reactivation. These studies will deliver insight into the mechanisms that drive herpesvirus
reactivation during co-infection and will increase our understanding of parasite modulation of tissue
resident macrophages. Harnessing the power of mouse model pathogens, these studies will advance our
understanding of pathogen co-infection.

Public health relevance
PROJECT NARRATIVE At any given time, humans are infected with multiple pathogens. The interaction of more than one pathogen in an infected host is poorly understood, because most experimental systems focus on single infections with individual pathogens. This work will examine how co-infections with a gammaherpesvirus and an intestinal parasite are different than single infections in mice.